Mechanisms and determinants of dynamic gene regulation during development and cellular differentiation

PROJECT SUMMARY
The human genome encodes information that specifies the development of an entire organism comprising at
least 10 trillion cells and more than 200 different cell types. The genome also contains the information to direct
appropriate responses to a host of environmental stimuli to maintain homeostasis and respond to challenges,
e.g. from microbial pathogens. Changes to this code or dysregulation of its interpretation underlie almost all
human diseases, including chronic inflammatory diseases, metabolic disorders, and cancer. Obtaining
mechanistic and quantitative understanding of gene regulation in individual cells is a crucial
prerequisite for a better understanding, and ultimately treatment, of diseases. Studying gene regulatory
processes in human tissues has been challenging because of their cellular heterogeneity and because most
human samples are not accessible to longitudinal observations and direct perturbations. However, the advent
of single cell genomic technologies, the development of human iPSC and organoid-based in vitro model
systems, and the availability of powerful tools for genetic perturbations have the potential to overcome these
challenges and to revolutionize biomedical research. In this proposal we combine the development of single-
cell multiomic tools that accurately profile multiple regulatory features within single cells or molecules with
mechanistic and disease-focused studies to understand how genetic and environmental perturbations of gene
regulatory processes disrupt cellular differentiation and underlie pathologies.

Public health relevance
PROJECT NARRATIVE A mechanistic and quantitative understanding of gene regulation in individual cells is essential for a better understanding, and ultimately treatment, of diseases. This project combines the development of single-cell multiomic approaches with human in vitro models and powerful tools for genetic manipulation to identify transcriptional and epigenetic mechanisms that regulate differentiation and development in human tissues and diseases.